Molecular characterization of reactive astrocytes in humans

Project Summary/Abstract
Astrocytes constitute at least one third of all cells in the human brain and are critical for the development and
function of the central nervous system. Reactive astrogliosis is a spectrum of cellular, molecular, and functional
changes of astrocytes found in a wide range of injuries and diseases, including epilepsy, brain tumor,
Alzheimer’s disease, Parkinson’s disease, stroke, inflammation, and traumatic brain injuries. Based on studies
of mouse models, reactive astrocytes play both beneficial and harmful roles in disease progression and neural
repair by secreting cytokines that regulate immune cells, producing growth factors, and forming scars that
insulate disease tissue from healthy tissue. However, little is known about the molecular and cellular changes
of astrocytes in human patients, due in part to the difficulties of purifying and culturing human astrocytes.
Previous methods of purifying human astrocytes rely on serum, which induces reactive astrogliosis in the
purification procedure, making it difficult to investigate reactive changes of astrocytes in patients. We recently
developed a novel purification and culturing method for human astrocytes without serum. Using our new
method, we will perform molecular characterization of reactive astrocytes purified from human patients with
epilepsy, brain tumor, Alzheimer’s disease, Parkinson’s disease, and arteriovenous malformation. In Aim 1, we
will characterize the transcriptome of reactive astrocytes and test the hypothesis that the molecular phenotypes
of reactive astrocytes are diverse in humans. In preliminary studies, we found that instead of being a single
state, there are diverse reactive states of astrocytes depending on the disease condition. We will examine the
function of molecules induced in reactive astrocytes in humans using in vitro cultures of human astrocytes. In
Aim 2, we will directly compare the responses of human and mouse astrocytes to a variety of harmful stimuli.
Our preliminary data showed that human and mouse astrocytes have different susceptibility to oxidative stress
and that harmful stimulus activates different signaling pathways in human vs. mouse astrocytes. These studies
has the potential to reveal what reactive astrocytes do or fail to do in human neurological disorders, and
provide new therapeutic targets for treating epilepsy, brain tumor, and neurodegenerative disorders.

Public health relevance
Project Narrative Reactive astrocytes have both beneficial and detrimental effect in neurological disorders. This project will characterize molecular phenotype of reactive astrocytes in humans and gain important insight into the roles of reactive astrocytes in disease initiation, progression, and neural repair. Molecular targets identified in this project have the potential to become novel therapeutic targets in treating epilepsy, brain tumors, Alzheimer’s disease, Parkinson’s disease, arteriovenous malformation, and stroke.